2025 RNA Nanotechnology Gordon Research Conference and Seminar

PROJECT SUMMARY
This R13 application requests partial funding to support the upcoming Gordon Research Conference (GRC) on
RNA Nanotechnology, which will be held in Ventura, CA on Jan 5–10, 2025, and the associated Gordon
Research Symposium (GRS), to precede it on Jan 4–5. The meeting will be co-chaired by Dolores Di Vizio and
Mark Bathe, who served as the co-vice chairs of the third GRC in January 2023, elected in 2019 at the same
GRC Meeting. Vice-chairs are Nils Walter and Alissa Weaver. RNA nanotechnology continues to grow as an
important field, with active research being carried out to elucidate fundamental principles of, and develop
innovative approaches to, the design and construction of RNA assemblies for diagnostic, therapeutic, and
structural applications in biotechnology and medicine. The pace of discovery and innovation in RNA
nanotechnology has significantly accelerated in the past two years with the success of the mRNA vaccines that
helped mitigate the spread of COVID19, which has spurred major research activity in other forms of mRNA
vaccines including principally also cancer vaccines. RNA nanotechnology is built on the unique properties of
RNA, including its structural versatility, its known biological functions, its ease of production and functionalization,
and its programmability, which altogether make it an ideal platform on which to build self-assembling
architectures with a variety of functional attributes for biomedical applications. This GRC focuses on linking
fundamental studies of RNA sequence, modifications, and structure to self-assembly and packaging to inform
translational studies using RNA nanotechnology in therapeutics and diagnostics with in situ characterization.
The 2025 meeting will cover a range of topics in nine sessions. Sessions on Structure-based Elucidation of
RNA Function, RNA Therapeutics, RNA Modifications, RNA Delivery, RNA Imaging & Characterization
"In Situ", RNA Immunology, RNA Cargo Selection, Transport, and Processing, RNA-based Diagnostics
and Biomarkers, and RNA Synthetic Biology will feature cutting-edge research on the molecular basis of
nucleic acid architectures and modifications, design and characterization of RNA for cancer vaccines and
therapeutics, and biophysical approaches to study and predict RNA function. Sessions on RNA cargo selection
in extracellular vesicles, RNA immunology, and RNA therapeutics will provide perspectives on the discovery,
isolation, and application of RNA from extracellular vesicles and learnings from viruses with an emphasis on
translational aspects of natural and synthetic RNAs in cancer diagnostics and therapeutics. The 2025 conference
will continue to emphasize robust representation of women and minority scientists. The invited speakers and
discussion leaders will include a mix of established researchers in the field and outstanding junior-level
investigators from around the world. The meeting will be advertised to a diverse audience to include early career
and under-represented minority scientists in the RNA nanotechnology and related fields. A Power Hour will
feature topics of diversity, inclusion, and opportunity for under-represented scientists.

Public health relevance
PROJECT NARRATIVE The accelerating field of RNA nanotechnology takes advantage of the structural and functional versatility of RNA to design and construct functional RNA assemblies that can be used for diagnostic, therapeutic, and research applications. The 2025 Gordon Research Conference and Seminar on RNA Nanotechnology will provide a forum for interdisciplinary interactions among scientists from diverse backgrounds and expertise, with a representation of junior scientists. The conference program aims to link fundamental research on structure- based elucidation of RNA function, design, and extracellular vesicle biology with applications of RNA nanotechnology for cancer vaccines, cancer screening and diagnosis, and other RNA-based therapeutics and vaccines.